Developing an App-Based Voice Clinical Decision Support Tool to Augment the Sensitivity of the Bedside Swallow Evaluation in Older Adults

PROJECT SUMMARY/ABSTRACT
The over-arching goals of Dr, Rameau's Beeson application are (1) to develop an easy-to-use, highly
accurate bedside clinical decision support tool to identify swallowing dysfunction in older adults using analysis
of features of their recorded voice, cough and speech, and (2) to become a leader in the nascent field of
geriatric otolaryngology with a focus on management of speech and swallowing issues in older adults with
Alzheimer's disease and related dementias (AD/ADRD).
Candidate: The applicant, Dr. Anaïs Rameau, is an otolaryngologist at Weill Cornell Medical College (WCMC)
who has demonstrated significant research ability and clinical interest in geriatric otolaryngology, especially in
the care of older adults with dysphagia. Dr. Rameau's long-term career goal is to become an independent
researcher and academic leader in geriatric dysphagia. She already laid significant foundations towards this
goal, developing close mentorship relationships, gaining broad research, clinical, management and leadership
skills, and experience as PI on multiple institutional and foundation grants.
Mentors: To achieve her objectives, Dr. Rameau has engaged an exceptional, transdisciplinary team of
mentors, who are highly successful, NIH-funded investigators and well-recognized leaders and experts in their
respective fields. Her mentorship team includes Dr. Mark Lachs, Co-Director of the WCMC Division of
Geriatrics, Dr. Michael Stewart, Chair of the WCM Department of Otolaryngology – Head & Neck Surgery, and
Dr. Sara Czaja, Director of the Center on Aging and Behavioral Research at WCM.
Research: In collaboration with bio-acousticians at the Cornell Lab of Ornithology, our research, both in an
excised canine model and a human pilot study, has suggested that conventional acoustic metrics of voice and
cough sound differ in important ways between patients with and without aspiration risk. These characteristics
may serve as biomarkers of dysphagia, and acoustic analysis of the patient's digitally recorded voice and
cough has the potential to effectively differentiate between normal and abnormal swallowing. Including multiple
characteristics, such as those specifically evaluating oral frailty, and combining the results may increase
accuracy of swallowing dysfunction identification, especially in older adults with AD/ADRD who are more prone
to silent aspiration. Adding non-linear methods and machine learning to conventional acoustic analysis may
also improve accuracy. Dr. Rameau proposes to use these techniques to develop a clinical decision support
tool that incorporates analysis of multiple characteristics of a patient's recorded voice and cough to determine
their aspiration risk. To increase the potential for use of this tool at the bedside, she will modify it for recordings
on a smartphone as part of a mobile application. Upon completion of this research, she plans to submit an R01
to prospectively examine the performance of the clinical decision support tool in a multi-site RCT in large,
diverse cohort of older adults.

Public health relevance
PROJECT NARRATIVE Swallowing dysfunction is common in older adults, and leads to significant morbidity, including aspiration pneumonia, malnutrition, and dehydration, and is the leading cause of death in older adults with AD/ADRD. Unfortunately, the bedside swallow evaluation currently used by speech language pathologists and nurses to detect swallowing dysfunction is unreliable, especially in individuals with AD/ADRD. We propose to develop a sensitive smartphone-based clinical decision support tool that incorporates analysis of multiple characteristics of a patient's recorded voice and cough to determine their aspiration risk.